Administrative Core

ADMINISTRATIVE CORE SUMMARY
The Administrative Core remains a central component of the Moffitt CSBC. It has oversight of the disbursal of
funds to the Projects and Cores. It is the clearinghouse for communication between the Moffitt CSBC and the
NCI and other members of the network. The core prepares the yearly reports to the NCI and will host the
External Scientific Advisory Board as well as the annual Integration Symposium. The Administrative Core will
provide travel support for the Moffitt CSBC team, invited guest speakers, and external advisors. To foster
scientific collaborations with researchers interested in related research with particular focus on Cancer
Systems Biology, the admin Core will be responsible for the distribution of information materials,
communication with other institutions, and collaborations with other relevant research programs. The admin
core plays a particularly critical role in the CSBC pilot projects. The administrative core will advertise pilot
funding opportunities, collect applications, organize the review panel and oversee the conduct of the funded
research. These funds will be used to support exploratory research that aligns with the evolutionary and
ecological theme of our CSBC as well as unexpected avenues of investigation that arise through developments
in the CSBC projects and core. Applications will be prioritized according to their (a) scientific merit, i.e.
significance and feasibility; (b) centrality to the mission of the Moffitt CSBC, i.e. an eco-evolutionary view of
cancer, and (c) innovation, i.e. a new paradigm. These projects will be supported by the $50,000 annual
institutional funding for pilot awards (see intuitional letter of support). In addition, in years 1-5 the Moffitt CSBC
budget includes another $50K for pilot awards. The Moffitt Cancer Center currently funds $50K per year to the
winner of the annual IMO transdisciplinary workshop (also guaranteed for the next 5 years). Finally, our CSBC
budget also provides an annual budget of $75,000 for trans-network projects (a requirement of the RFA) that
will enrich for center-center collaborations, ensuring the CSBC network flourishes.